Psychobiological Mediators of the Impact of Pregnancy Stress on Maternal Sensitivity

PROJECT SUMMARY
Poor mental health is prevalent in stressful pregnancies, with at least 10-15% of pregnant women
above the clinical thresholds for a mental health disorder. Mothers affected by mental health disorders are less
likely to engage in sensitive caregiving and may be at risk for engaging in harsh and punitive behaviors that
lead to a host of poor child outcomes. Pregnancy stress also disrupts the endocrine profile of pregnancy, which
is highly problematic because circulating estradiol and progesterone across pregnancy are known to be strong
biological determinants of early postpartum caregiving in humans and all other mammals. While maternal
mental health and sex steroids across pregnancy are each affected by stress and influence postpartum
caregiving, how they coordinate with each other to impact early maternal sensitivity is completely unknown.
We hypothesize in this R03 project that maternal mental health symptoms and maternal sex steroid
hormones are critical biopsychosocial mediators of the relationship between pregnancy stress and low
maternal sensitivity. The Specific Aims of this proposed basic research project are to: 1) Determine the
individual trajectories, and coordinated changes in trajectories, of mental health symptoms (i.e., depression,
trait anxiety, pregnancy-specific anxiety, PTSD) and sex steroid hormones (estradiol, progesterone, and their
ratio) across pregnancy to early postpartum, and 2) Determine whether these trajectories, including changes
over time, mediate the relationship between pregnancy stress and postpartum maternal sensitivity.
The proposed project will be the first longitudinal, prospective study determining how the trajectories of
maternal mental health symptoms and sex steroid hormones (alone and coordinating together) mediate the
relationship between pregnancy stress and maternal sensitivity in an economically, educationally, and racially
heterogeneous sample of women. Our proposed study's secondary analysis will capitalize on multi-method
data previously collected through our team's ongoing NICHD R01-funded project that brings together both
psychological and biological perspectives to understand how pregnancy stress impacts maternal/child
outcomes. Knowledge gained by this proposed R03 study will specifically advance understanding about how
pregnancy stress affects women's mental health and endocrine state to impact early caregiving and will help
identify critical target points for prevention and intervention with the most at-risk women.

Public health relevance
PROJECT NARRATIVE Many women experience high psychosocial stress during pregnancy, which can act through many biopsychosocial factors to derail postpartum maternal sensitivity to the infant and other aspects of maternal caregiving. By capitalizing on data our team has collected through a large longitudinal study of an racially and economically diverse group of pregnant and early postpartum women, we will determine the trajectories of maternal mental health symptoms (depression, anxiety, PTSD) and sex steroid hormones (estradiol and progesterone) across pregnancy, how these trajectories interact, and how alone and together these trajectories mediate the relationship between pregnancy stress and postpartum maternal sensitivity. Knowledge gained by our study will greatly advance our understanding of the biopsychosocial mechanisms through which pregnancy stress influences early maternal caregiving behavior, with implications for intervention and treatment for women and infants most at risk for experiencing high life stress and difficulties with maternal caregiving.